Investigating the impact of abnormal lipid metabolism on mouse intervertebral disc

Project Summary/Abstract
Hyperlipidemia, i.e. elevated serum lipids, has been identified as a risk factor for intervertebral disc (IVD)
degeneration (IDD), but the underlying mechanism remains elusive. Epidemiologic studies have suggested
mechanisms underlying hyperlipidemia and IDD other than obesity-induced mechanical stress, suggesting that
elevated lipids may directly affect metabolic homeostasis in the IVD. However, oxygen demanding lipid
metabolism has been considered minimal in hypoxic IVD, which has impeded investigation of this possibility
thus far. Our preliminary data have uncovered an active lipid metabolism in mouse IVDs: they take up systemic
lipids, undergo fatty acid oxidation (FAO) and store them in lipid droplets (LD). Furthermore, when lipid
metabolism is disrupted by blocking FAO in a genetic mouse model or by lipid overload in a high-fat diet
(HFD)-induced hyperlipidemia model, we observed significant lipid accumulation in nucleus pulposus (NP)
cells. Histological evaluation revealed that in addition to abnormal lipid accumulation, there was a significant
decrease in disc height and proteoglycan content in the NP in the HFD model. Biomechanical tests revealed a
compromised mechanical strength of the IVDs from HFD-fed mice. In humans, the primary functional role of
the IVD is to provide mechanical support to the spine. Reductions in proteoglycan content, disc height, and
mechanical strength are early signs of IDD and can lead to severe IDD later in life. To investigate whether the
early IDD changes caused by abnormal lipid metabolism can progress to severe IDD in the mouse models
whose IVDs are not weight-bearing, we aim to comprehensively assess the mechanical properties of the
intervertebral disc using an in vivo spinal instability-induced IDD mouse model in addition to the ex vivo testing
system. In addition, we will establish a spatial lipidomics approach (Mass Spectrometry Imaging) and single-
cell RNA sequencing in this training program to study metabolic changes and cellular responses to abnormal
lipid metabolism in mouse models. We will also evaluate back pain-like behaviors in these animal models. The
results of this project will reveal a novel mechanistic link between hyperlipidemia and IDD and lay the
foundation for future studies exploring diagnostic/prophylactic/therapeutic approaches for lipid-related spine
diseases.

Public health relevance
Project Narrative Abnormal lipid metabolism in cells can cause energy imbalance, abnormal lipid accumulation, and insulin resistance, leading to cellular dysfunction and disease. Based on our preliminary findings that mouse intervertebral disc cells undergo active lipid metabolism and that abnormal lipid metabolism causes lipid accumulation in these cells, we plan to further investigate how abnormal lipid metabolism affects IVD functions. We believe that the findings from this project will lay the foundation for future studies exploring a novel mechanistic link between metabolic diseases and disc disease.